Cancer Research Training and Education Coordination

ABSTRACT
The mission of the UCCC Cancer Research Training and Education Coordination (CRTEC) office is to serve and
improve the care of cancer patients by fostering the careers of early-stage investigators and providing education
and training activities across the spectrum of academic levels. CRTEC's objectives are to introduce and
encourage the next generation of trainees to pursue careers in cancer research, nurture the careers of junior
faculty, increase the participation of individuals from underrepresented backgrounds, and provide education and
training activities to all faculty. Strategies employed include leveraging University of Colorado Anschutz Medical
Campus' (UCAMC) and UCCC members' strong commitment to education and training; developing innovative
approaches for training and mentoring cancer researchers; periodically evaluating and refining cancer-related
education activities; interacting closely with UCCC research programs; and collaborating with UCCC's
Community Outreach and Engagement (COE) Office to establish novel activities relevant to our catchment area.
These objectives are accomplished through the following aims: Aim 1: Provide comprehensive cancer research
education, training, and career enhancement activities across a wide continuum of trainees and faculty. Aim 2,
Coordinate cancer center-wide activities for mentoring the next generation of basic, clinical and population
science researchers. Aim 3 Nurture the pipeline and expand the diversity of cancer researchers while integrating
basic, clinical, and population health research. UCCC fills a unique niche in the nation's Cancer Center program
by serving a diverse catchment area that includes a large Latino and rural population. UCCC offers a rich
environment for training, educating, and helping advance careers in clinical, basic, and population cancer
research. From 2016-2020, trainees ranging from middle school to faculty, administrative staff, and community
members, participated in an array of cancer-specific training and education activities offered by UCCC. In strong
support of cancer-related career training activities and career development, the UCCC and UCAMC invested
~$8.6M since 2016 in these efforts. The UCCC CRTEC serves as the organizational and support center for
education and training, mentoring, preparing education-related grants and training programs, sharing best
practices, monitoring, and refining research training needs, and program evaluation.